CB2 Cannabinoid Mechanisms for Suppressing Opioid Tolerance and Dependence

Despite significant limitations, opioids remain a mainstay for the treatment of severe acute and chronic pain.
Two clinically significant limitations that accompany the long-term therapeutic use of opioids are: (1) The
development of tolerance (requiring escalating doses of opioid to maintain the desired therapeutic benefit or
leading to diminished benefit with constant dose) and (2) Physical dependence (withdrawal symptoms on
cessation of opioid use, which are very unpleasant, and seeking their avoidance may increase the risk for
opioid addiction). Currently, there are no practical approaches for decreasing opioid tolerance or suppressing
the development of physical dependence. However, in exploring potential interactions between CB2
cannabinoid receptor (CB2R) and mu opioid receptor (MOR) signaling, we made the exciting discovery that
certain CB2 agonists effectively prevented the development of tolerance to opioid-induced anti-allodynic
efficacy in a murine neuropathic pain model, while also blunting the physical dependence that accompanies
chronic morphine exposure. These findings, if they can be translated to humans, hold the promise to
significantly improve the clinical use of opioids. On the path to translating these findings, we will complete
three specific aims to better understand how CB2 and mu opioid receptor agonists interact to suppress opioid
tolerance and dependence:
Aim 1: Identify the CB2-expressing cells engaged by LY28282360 to prevent opioid tolerance. We will
delineate the cell types responsible for the ability of LY2828360 to block development of morphine tolerance
and identify site of action using both pharmacological manipulations and a conditional deletion approach.
Separate studies will target primary afferent nociceptors vs. microglia.
Aim 2: Define the conditions under which CB2 agonists suppress opioid-induced physical dependence.
We will delineate the cell types responsible for the effects of LY2828360 on opioid dependence, as measured
using naloxone precipitated opioid withdrawal, using both pharmacological manipulations and a conditional
deletion approach. Separate studies will target primary afferent nociceptors vs. microglia.
Aim 3: Mechanistic characterization of CB2R/MOR interaction. We will characterize CB2 ligands for their G
protein/arrestin signaling bias as well as their kinetics of G protein activation. We will also determine if the slow
activation of G protein signaling by LY2828360 and related CB2 agonists is due to the kinetics of receptor
binding. Finally, if the results of Aims 1 or 2 suggest that MOR and CB2R are interacting in the same cell, we
will characterize the differences in CB2R/MOR crosstalk between slowly and rapidly signaling CB2 agonists.
Completion of these aims will fully characterize interactions between CB2 and opioid receptors in preclinical
and cell-based models. These studies will help define the clinical settings where CB2 agonists may be useful in
countering two major limitations on the use of opioids in treating chronic pain.

Public health relevance
Opioids have been used for centuries to treat chronic pain, but their therapeutic usefulness is limited by the tolerance that develops to their sought after effects as well as adverse effects, particularly physical dependence. This proposal fully characterizes and examines the cellular and molecular basis of a novel strategy that we recently discovered to prevent opioid tolerance and dependence. Importantly we are evaluating a functionally-biased CB2 agonist that has been shown to be safe in Phase I and II clinical trials; thus our findings can be quickly translated from the laboratory to the clinic.